Neuromarkers for craving and drug use

Project Summary/Abstract
Substance use disorders (SUDs) are the most common, costly, and deadly psychiatric conditions1-3. Our
approach centers on the development and validation of neuromarkers – measurable, brain-based indicators of
pathophysiology, risk, and resilience. In R01DA043690, we used machine learning and fMRI data to create
a cross-validated neuromarker for drug craving, a core feature and diagnostic criterion for SUDs in DSM-
51-3 that predicts drug use and relapse4. The resulting Neurobiological Craving Signature (NCS)5 predicts the
intensity of cue-induced drug and food craving in new individuals with cocaine, alcohol, and tobacco use
disorders (p<0.0002, d=0.93), discriminates between individuals with vs. without SUDs with 82%
accuracy5, and is modulated by a regulation strategy drawn from cognitive behavioral treatment (CBT)5. In this
proposal, we validate the NCS based on FDA-NIH-defined criteria6 and unpack its underlying neurobiological
systems. For this, we have curated a large database including 82 existing cue reactivity fMRI studies (total
N=5,475) from our lab, other labs, the ENIGMA consortium, and NCANDA (from the NIMH Data Archive).
In Aim 1, we propose to validate the NCS towards research and clinical uses, following the FDA-NIH
Biomarker Working Group6 guidelines. We will assess (1a) Generalizability, by testing whether the NCS predicts
craving across drugs, stimulus types, sex/gender, and racial categories (N=3,844); (1b) Bias in
over/underpredicting selected groups (sex, race, drug type, treatment-seeking status; N=3,844); (1c)
Discriminant validity, by comparing the NCS with neuromarkers for other affective states (N=5,475)7-11; (1d)
Diagnostic validity, by testing NCS-based discrimination of drug users from non-users (N=1,773); (1e)
Predictive validity, by testing if the NCS can predict which individuals will respond to psychological (N=257) or
pharmacological treatments (N=562) vs. control; and (1f) Prognostic validity, by testing if the NCS can predict
future drug use or relapse after treatment (N=860). To address potential limitations on generalizability as well as
any detected bias, we include plans to fine-tune models for subgroups (e.g., sex, race, drug type) if needed.
In Aim 2, we will characterize the neurobiology of the NCS and its components, using an interpretable
machine learning approach12, 13. We identify key nodes contributing to craving prediction and deploy a series of
techniques to identify craving-related brain pathways. We combine multivariate pattern-based pathway
identification14 with dynamic connectivity to estimate both population-level and individualized connectomes. We
will (2a) test the predictive power of connectomes above and beyond activity patterns; (2b) assess individual
variability in pathway strength; (2c) test whether drug cues enhance and increase functional integration; and (2d)
identify latent brain states associated with craving and relapse. Deliverables include a refined understanding of
connectivity states linked to craving and SUD recovery vs. relapse, and connectivity-based predictive models
composed of specific neural pathways that can be validated across species and methods.

Public health relevance
Project Narrative This project centers on the development and validation of neuromarkers – stable indicators of biological processes linked to pathophysiology, risk, and resilience – and in particular, the Neurobiological Craving Signature (NCS; Koban, Wager, and Kober 2023, Nature Neuroscience), the first neuromarker validated to predict craving and distinguish drug users from non-users across multiple studies/drug-using groups. Here we propose to further validate the NCS on a curated dataset including 5,475 participants from 82 studies, and to characterize its underlying neurobiological ingredients – crucial steps towards developing useful diagnostic, predictive, and prognostic neuromarkers of substance use.